COBRE-DIABETES

PROJECT SUMMARY/ABSTRACT This application is for a supplement to support a Phase I Center of Biomedical Research Excellence (COBRE) at the University of Hawaii (UH) on Diabetes (1P20GM113134-04) in response to funding opportunity NOT- GM-21-029, “Administrative Supplements for Equipment Purchases for NIGMS-funded Center and Core Facilities”. The COBRE-Diabetes has developed a Resource Core dedicated to supporting career development for young investigators and to foster diabetes-related research in the state, which is acutely needed. It is estimated that a third of the State’s population will be living with diabetes by the year 2050. The COBRE-Diabetes Resource Core goal is to establish a new and easily accessible modern infrastructure to support investigations in the mechanisms, diagnosis, prevention, and/or treatment of diabetes to address health disparities in the minority populations in Hawaii. Our unique aim is to Maintain the growth and enhance the sustainability of Resource Core. With this proposal, we will optimize our core capacity in order to continue capacity improvement that has been successfully initiated in the first Phase of COBRE-Diabetes funding. In order to accomplish this objective, we request funding for the acquisition of two new pieces of equipment. We hope to replace an existing obsolete Xenogen Vivo Vision IVIS Lumina Imaging system with an IVIS Lumina XRMS in vivo imaging system. This is equipment offers cutting edge in vivo fluorescence and bioluminescence technology combined with low dose 2D X-ray allowing for non-invasive and precise metabolic analyses. This will give us an expanded capacity with multiple animals to perform longitudinal studies. The second equipment is an i-STAT clinical blood analyzer that operates with the advanced technology of single- use i-STAT test cartridges offering a wide array of tests on a single platform, including rapid tests for electrolytes, chemistries, blood gases, hematocrit and hemoglobin or the fast evaluation of metabolic status and renal function. This system uses minimal blood volumes, which will not require animal (mouse) sacrifice. Blood analyses are currently done using individual and dedicated kits that is laborious or contracting services outside of the University. There are many projects ongoing in the DRC that can best be performed in Hawaii. Our distance from US mainland requires that we develop a fundamental repertoire of Core services for diabetes research with COBRE resources. The Dean of the Medical School has committed to provide institutional support to cover the cost of operation for three years after the purchase of these equipment.

Public health relevance
PROJECT NARRATIVE This application is for a supplement to support a Phase I Center of Biomedical Research Excellence (COBRE) with the purchase of an IVIS Lumina XRMS in vivo imaging system which offers cutting edge in vivo fluorescence and bioluminescence technology combined with low dose 2D X-ray and an i-STAT clinical blood analyzer to improve the capacity of our core services as we prepare to submit the renewal of this COBRE- Diabetes.